REGULATION OF ASCIDIAN SPERM ACTIVATION AND PENETRATION

The long-term goal of this project addresses the biomedical problems of fertility/ fertilization and intracellular movement of organelles via studies of ascidian fertilization at the cellular and biochemical levels. Early events of fertilization include sperm-egg binding, sperm activation and, subsequently, sperm penetration of egg vestments, processes which ultimately lead to fusion of sperm and egg plasma membranes. The cellular mechanisms of sperm activation and penetration, as triggered by sperm-egg binding, are the foci of this project. Simply stated, the binding-activation-penetration process involves anchorage of sperm to outer egg vestments and movement of this site to the mitochondrion which then moves off the sperm head and down the tail injecting the sperm head through the outer egg vestments. It is hypothesized that signalling events which cross the membrane must connect binding to activation and that rearrangement of force-producing cytoskeletal elements must connect activation to mitochondrial migration. The specific aim of this project is to use a reversibly permeabilized sperm preparation to study both of these connections. Investigating the transmembrane signalling connection requires loading of cells with activators or blockers to indirectly test for the presence of the components of one of several possible second messenger systems (in this case, the polyphosphainositide-linked mechanism). Direct evidence will be gathered by biochemical analysis of some of the protein members of the pathway, by measuring the appearance of the products of their actions, and by studying their behavior in the presence of antibodies which either identify or interfere with them. This polyphosphainositide-dependent regulatory pathway was chosen because, in some cells, it is known to elevate intracellular pH and calcium, both of which occur as part of ascidian sperm activation. Studying mitochondrial movement requires probing the biochemical nature and cellular location of participating cytoskeletal proteins. The presence of specific cytoskeletal proteins and motility motors will be established by polyacrylamide gel electrophoresis and immunoblotting. The cellular location of these proteins will be studied by indirect immunofluorescence and immunoelectron microscopy.